HEREDITARY PERSISTENCE OF FETAL HEMOGLOBIN

The purpose of this study is to investigate the mutational basis of hereditary persistence of fetal hemoglobin (HPFH) and elucidate the relationship between these mutations and globulin gene expression.